SMART Polymer Fibers For Tampon-Like Nonsteroidal Contraceptive Devices

PROJECT SUMMARY/ABSTRACT
Natural fertility requires spermatozoa to migrate through viscoelastic secretions and to overcome the physiolog-
ical acidic environment of the female reproductive tract. Our preliminary data show that novel mucoadhesive,
bioresponsive polymer compositions maintain a physiologically acidic pH environment upon exposure to seminal
fluid and, at the same time, dramatically increase viscoelastic properties, which negatively impacts sperm motil-
ity. Therefore, it is hypothesized that - upon exposure to semen - the novel mucoadhesive, bioresponsive com-
position rapidly transforms the vaginal cavity into an inhospitable environment for sperm. We propose to explore
an innovative approach to on-demand non-steroidal contraception for women using SMART (= System
Mute until Activation by a Remote Trigger) polymer fibers that maintain a physiological, protective vag-
inal environment upon exposure to seminal fluid resulting in infertility. This high-risk/high-reward research
strategy is fundamentally different from conventional nonsteroidal contraceptive methods as it represents an
innovative bioengineering concept intended to reach the human testing phase (i.e., IND milestone) much faster
and at a lower cost than conventional development programs focusing on medicinal chemistry approaches.
In this administrative supplement, we will test whether incorporation of drug molecules intended for pharmaco-
logical modulation within the vaginal cavity alters the engineering design space and contraceptive efficacy of
SMART polymer fibers. In Aim #1, we will delineate electrospinning engineering parameters for non-woven,
SMART fiber mats that contain amphiphilic microbicides exhibiting different physiochemical properties. We will
test their ability to rapidly reconstitute into an acidic gel phase that exhibits desired mucoadhesive and biore-
sponsive properties. In Aim #2, we will assess contraceptive efficacy of microbicide-containing SMART fiber
mats in vitro and compare the results to drug-free SMART polymer fibers. Collectively, these results will define
the adaptive space for clinical development of SMART polymer fibers to meet women’s preference.

Public health relevance
PROJECT NARRATIVE Novel nonsteroidal contraceptive methods are needed for men and women that act prior to fertilization in order to prevent unintended pregnancies. This application seeks to develop novel biomaterials that enable fabrication of nonsteroidal contraceptive devices suitable for self-administration by women to expand the choices for the personal decision of managing fertility throughout their reproductive lives. This high-risk/high-reward research strategy is fundamentally different from conventional nonsteroidal contraceptive methods as it represents an innovative bioengineering concept intended to reach the human testing phase (i.e., IND milestone) much faster and at a lower cost than conventional development programs focusing on medicinal chemistry approaches.